The TGFÃÂÃÂÃÂÃÂ² Signaling Pathway in Development and Cancer

PROJECT SUMMARY/ABSTRACT
Phenotypic plasticity and its regulation by contextual signals is of central importance to tumor biology. TGFβ is
a major regulator of cell phenotype during development, tissue homeostasis, regeneration, and cancer. Our long-
term goal is to elucidate TGFβ signaling and the principles that govern its effects on normal and neoplastic cells.
This proposal is based on our long-standing contributions to delineating the TGFβ signal transduction pathway,
its context-dependent effects, and its aberrant activity in tumorigenesis and metastasis. The proposed work
builds on recent progress towards understanding how TGFβ-activated SMAD transcription factors regulate
differentiation in stem and progenitor cells (Aragón et al Genes Dev. 2019; Wang et al Cell Stem Cell 2017), the
basis for TGFβ-mediated tumor suppression and the evasion of this effect (David et al Cell 2016; Huang et al
Cancer Disc. 2019), and the development of experimental models of dormant metastasis to expose the role of
TGFβ in this poorly understood, yet highly significant aspect of cancer (Malladi et al Cell 2016). Moreover, we
recently elucidated how TGFβ triggers epithelial-mesenchymal transitions (EMTs) in pancreatic ductal
adenocarcinoma (PDA), lung adenocarcinoma (LUAD), and embryonic stem (ES) cells, and how these
phenotypic plasticity events are coupled either to fibrogenesis or to differentiation depending on the epigenetic
context (Su et al Nature 2019). Based on these advances and unique experimental models and human tumor
single-cell analytics that we have developed, we will address long-standing questions of growing importance:
How does TGFβ signaling regulate epithelial cell plasticity in development and cancer? What is the role
of TGFβ-induced intra-tumoral fibrosis during tumorigenesis? What is the relevance of this mechanism
to TGFβ-induced organ fibrosis? How does TGFβ drive metastasis-initiating cells into EMT-linked growth
arrest? Does this state render cancer cells immune-evasive during metastasis dormancy? To investigate
these questions, we will dissect an obscure RAS effector, RREB1, which we recently identified as a key partner
of TGFβ-activated SMAD transcription factors in the induction of fibrogenic and developmental EMTs. We will
elucidate the role of EMT-linked intra-tumoral fibrosis in tumor growth and metastasis. Focusing on metastasis-
initiating cells, we will follow recent evidence that TGFβ imposes a quiescent, immune evasive state that provides
long-term survival to dormant metastasis cells and potentially resistance immunotherapy. Collectively, these
studies will provide knowledge and experimental models to delineate the role of TGFβ in fibrosis, tumor invasion
and metastasis, and will better define how and when to target TGFβ in cancer.

Public health relevance
PROJECT NARRATIVE Building on long-standing expertise of this lab on TGFβ signaling in development, regeneration and cancer, this project will elucidate how TGFβ regulates epithelial phenotypic plasticity in concert with intra-tumoral fibrosis to promote tumor invasion and metastasis, and how TGFβ stimulates entry of metastasis-initiating into quiescent, immune-evasive states that support their survival as residual disease. This work will increase our understanding of how to target TGFβ in order to suppress metastatic relapse and resistance to therapy. 1